Characterizing the transcriptional and neuro-immune consequences of loss of high-confidence bipolar disorder risk gene KDM5B

Project Summary: Characterizing the transcriptional and neuro-immune consequences of loss of
high-confidence bipolar disorder risk gene KDM5B.
Bipolar disorder (BD) is a prevalent psychiatric condition affecting approximately 5.7 million individuals in the
United States. The two-hit hypothesis posits that a combination of genetic predisposition (first hit) and
environmental stressors (second hit) can trigger the onset of disorders such as BD. The Bipolar Exome
(BipEX) consortium has identified KDM5B, a gene coding for a histone demethylase involved in immune
regulation, as a substantial risk factor for bipolar disorder, suggesting its mutation as a potential first hit. Stress
is a major risk factor for BD, elevating glucocorticoid 'stress' hormones, which, in turn, trigger immune
responses. Chronic stress can drive microglia into reactive states, resulting in activity-dependent synaptic
remodeling in key brain regions, which include the release of immunomodulatory factors and synaptic pruning,
making it a relevant second hit for altering brain function. We hypothesize that mice with heterozygous loss
of KDM5B are more susceptible to stress, and present abnormal gene expression and neuro-immune
responses that will lead to synaptic dysregulation. Our specific aims are: 1 – to investigate the impact of
stress on behavior and gene transcription of WT and KDM5B heterozygous mice, and 2 - to characterize the
neuro-immune responses in KDM5B+/- mice that can influence synaptic phagocytosis. For aim 1, we will assess
behavioral patterns that could be altered in KDM5B+/- mice under basal and stress-induced conditions, and
determine the transcriptomic changes in KDM5B mutant mice and wild-type controls in response to stress. For
aim 2, we will profile microglia-produced cytokine expression in tissue lysates and isolated microglia, and
characterize stress-related engulfment of synaptic markers by microglia. Our methodology involves subjecting
KDM5B+/- and wild-type mice to a chronic unpredictable stress (CUS) paradigm followed by Motion Sequencing
(MoSeq) behavioral analysis to determine the behavioral susceptibility of KDM5B+/- mice to stress. For
molecular analyses, we will use single-cell RNA sequencing to elucidate transcriptomic changes within
microglia and other non-neuronal and neuronal cell populations following loss of KDM5B, which as a histone
demethylase is known to be involved in gene regulation. Proteome Profiler Mouse Cytokine Array assays will
be used to examine alterations in soluble proteins released by microglia. Additionally, FEAST (Flow cytometric
Engulfment Assay for Specific Target Proteins) analysis will detect synaptic pruning by microglia in a single-cell
resolution manner. The insights gained by this proposal will enhance our understanding of neuro-immune
interactions under stress conditions and provide insight into the basic function of BD risk gene KDM5B.

Public health relevance
Project Narrative The two-hit hypothesis of psychiatric disorders posits that a first hit, such as genetic predisposition, primes an individual for a second hit, such as chronic stress, towards developing disease. This proposal will test the hypothesis that a newly identified high-confidence risk gene for bipolar disorder, KDM5B, predisposes mice towards exacerbated neuro-immune responses to stress. The result of this proposal will be a deeper biological understanding of an under-studied bipolar disorder risk gene and a greater insight into neuro-immune mechanisms underlying psychiatric disorders.